Selectivity/Spec Profiling (Florida)

D6.0 SELECTIVITY PROFILING CORE: A key challenge to the MLPCN strategy is the need to have sufficient capacity for selectivity screening data, essential for the optimization of selective chemical probes. The TSRI Center has instituted two generic approaches that enable these data to be developed and integrated in chemical optimization for broad ranges of biological targets. This area is one example of Center-driven scientific choices that have been of high value and impact broadly. Two such approaches, one for transcription and one for broad profiling of enzyme inhibition by catalytic family, are reduced to practice and presented.